Mechanisms of Staphylococcus aureus virulence

In FY2025, we continued our long-standing research in the area of Staphylococcus aureus biology and pathogenesis. S. aureus is among the most frequent causes of bloodstream, skin and soft tissue, and lower respiratory tract infections in much of the world, including the United States. Notably, the pathogen has become increasingly resistant to antibiotics over the past several decades and methicillin-resistant S. aureus (MRSA) is a leading cause of healthcare-associated infections. S. aureus can also develop reduced susceptibility to vancomycin, thereby limiting options for treatment of severe infections.